High channel count electrophysiology and data processing for freely-moving animals

PROJECT SUMMARY
Simultaneous recording and stimulation of larger populations of neurons distributed throughout the brain is
needed to rigorously evaluate theories of neural computation at the cellular level in mammals. Previously, we
introduced a direct-to-disk data acquisition architecture (Kinney et al., 2015) designed to work with
close-packed silicon probes (Scholvin et al., 2016) to enable 1000-channel neural recording in head-fixed
animals (Preliminary Data). Through pilot studies we demonstrated the successful recording of terabytes of
neural spiking activity (Preliminary Data), but also discovered some shortcomings of the architecture. Two
design elements in particular were limiting. First, our headstages were too bulky for freely-moving experiments.
Second, our acquisition hardware did not have the ability to quickly analyze all 1000 channels of data. As a
result, it took days to weeks to understand the neural activity content of the terabyte-size recordings. For
ultra-high-channel count neural recordings to become routine, the acquisition architecture must allow and
facilitate rapid online and offline analysis of large amounts of data. A computer architecture with local data
storage and analysis is favored, since a 1000-channel recording (e.g. 1000 channels sampled with 16 bits at
30 kHz) generates neural data at a sustained rate that exceed typical (gigabit ethernet) network connection
speed to compute clusters or the cloud.
Accordingly, we propose a 1024-channel silicon probe for freely-moving electrophysiology
experiments in combination with a data acquisition system optimized for easy data analysis. The novel
silicon probe will record and stimulate 1024 closed-packed sites, be compact enough for freely-moving rodent
experiments, and reduce headstage cost by a factor of 5 (<$1 per channel). Furthermore, the redesigned
acquisition hardware will not only capture 1024 channels of neural data and store to solid-state drive over a
high-speed bus, but will now also copy the data to a GPU for spike sorting and RAM for visualization both
online and offline. To test the system, we will perform 1024-channel freely-moving neural recordings in rodents,
in collaboration with (at least) 3 labs with expertise (see Letters of Support).

Public health relevance
PROJECT NARRATIVE Electrophysiological recording systems allow direct observation of neural activity in animal subjects. This facilitates the study of crucial neuroscientific topics such as development, learning and memory, and cognition, as well as brain diseases such as Alzheimer’s, epilepsy, Parkinson’s, and depression. LeafLabs’ tools for performing and analyzing high-channel count electrophysiology experiments in freely-moving rodents will allow researchers to collect and interpret neural data at a large scale.